A Molecular Switch Controlling Antigenic Variation in Malaria Parasites

Abstract
Malaria is a major cause of morbidity and mortality across the developing world. The major causative agent of
severe malaria is the protozoan parasite Plasmodium falciparum. Key to its virulence is its effective use of
antigenic variation in subverting the host immune system. P. falciparum expresses a transmembrane protein that
is trafficked out of the parasite and into the membrane of the erythrocyte in which it resides. This protein, PfEMP1,
is essential to the parasite as it mediates binding of the infected erythrocyte to the host vasculature, thereby
preventing clearance by the spleen. At the same time, PfEMP1 is immunogenic and the host will mount an
adaptive immune response specifically targeting this protein. The parasite evades this response through the
expression of immunologically distinct isoforms of PfEMP1, each encoded by different members of the var
multicopy gene family. There are approximately 40-90 var genes encoded in the genome of any given parasite
isolate and they are expressed in a mutually exclusive fashion. While the epigenetic mechanisms controlling the
activation and silencing of var genes have been identified, little is known regarding the regulation of
transcriptional switching between genes. Due to the limited number of var genes available within the parasite
genome, purely stochastic switching between genes would likely result in premature expenditure of the antigenic
repertoire. Mathematical algorithms have provided models proposing an optimized switching network that
enables the parasite to efficiently utilize its full complement of var genes over the course of an infection. These
models have proposed a role for a “sink-node” within the network that coordinates transcriptional switching.
There is an increasing body of evidence that a highly conserved, unique var gene, var2csa, is the hypothesized
“sink-node”. var2csa encodes the PfEMP1 responsible for pregnancy associated malaria. Surprisingly, high
levels of var2csa transcripts are found in non-pregnant individuals, suggesting an additional role for this gene.
When the var2csa locus is deleted in cultured P. falciparum, the resulting parasites are unable to undergo a var
gene transcriptional switch, indicating the potential for var2csa to serve as the “sink-node.” This proposal looks
to uncover the mechanisms by which var2csa fulfills this second role in coordinating switching. var2csa is unique
in that it is the only var gene with a highly conserved upstream open reading frame (uORF). The presence of a
uORF is known to influence transcript stability, reduce downstream translation and can induce gene silencing.
Specific Aim 1 is designed to investigate the role of the uORF in modulating var2csa mRNA stability and
transcriptional activation through the nonsense mediated decay (NMD) pathway. Specific Aim 2 will examine
the role of initiation factor conformation in regulating translation of the var2csa transcript. The phosphorylation
state of eIF2α can respond to altered nutrient levels, resulting in changes in translational initiation. Together, this
proposal will determine the role of the uORF in regulating var2csa’s proposed dual function.

Public health relevance
Project Narrative Malaria is one of the world’s most devastating infectious diseases, causing greater than 400,000 deaths per year and primarily impacting young children living in sub-tropical and tropical regions. Key to the virulence of the deadliest malaria parasite, Plasmodium falciparum, is its ability to evade the human immune system. This proposal seeks to understand the mechanisms by which this parasite can escape our natural immune responses and will aid in the developments of new approaches to reduce the impact that this disease has on the world.